BIOGENESIS OF MEMBRANE LIPIDS IN ANIMAL CELLS

The present study has as its objective to understand the regulation, biosynthesis, and function of membrane phospholipids in mammalian systems. Toward this end we are employing a combination of genetics and biochemistry by utilizing Chinese hamster ovary (CHO) cells. These have the advantage that: 1) they can be cloned from single cells; and 2) biochemically-defined mutants can be isolated in which the membrane composition is altered.